Identifying Efficient Health Care Providers: Evidence from Hospital Closures and Registry Data

PROJECT SUMMARY – PROJECT 3

Clinicians treating patients in community settings face significant challenges;; evidence can be lacking for the
patients they typically see, particularly for frail elderly people who are often excluded from randomized trials,
and community hospitals may not necessarily provide the same level of expertise as the large academic
medical centers where trials often take place. To address concerns about the potential for poor quality care,
many institutions are using risk-­adjusted performance measures, but there is considerable uncertainty about
whether they can be interpreted in a meaningful way given the potential for unmeasured confounding and
consequent biases. In this project, we use a combination of trial data, registry data, and claims data
augmented with natural-­experiments, to address these concerns along three dimensions. First, we harness the
strength of a large registry, the Vascular Quality Initiative for patients with lower-­extremity peripheral vascular
disease, to estimate the extent of heterogeneity across patients, and hospitals, in treatment effects;; we plan to
validate our estimates when an ongoing clinical trial (BEST-­CLI) is completed. Second, we use the entry and
exit of hospitals and physicians, and the consequent impact on population-­level health, to assess the validity of
our provider performance measures derived from claims. Finally, we use the natural experiments of provider
entry and exit to understand whether these sudden changes are more burdensome for vulnerable populations
such as minority patients and those with a diagnosis of Alzheimer’s Disease and related dementia (ADRD).
We build on key strengths of the NIA P01, including extensive Medicare claims data, access to clinical
registries, economic modeling, and most importantly detailed knowledge of the clinical setting through
collaboration between clinicians and social scientists. This project will contribute to other projects (e.g., 4 and
2), and has the potential to substantially improve patient outcomes by improving guidelines for patient and
hospital choice.